The Architecture of High Value Healthcare

Project Summary
In 2016, faculty from Johns Hopkins medicine invited all academic medical centers in the US to collaborate in
creating the High Value Practice Academic Alliance (HVPAA), a multi-institutional, multispecialty organization
designed to efficiently and effectively advance value-based quality improvement initiatives on a national scale.
As of January 2022, more than 200 faculty leaders from 100 academic centers in the US and Canada serve as
institutional or departmental representatives. Members convene on monthly conference calls for information
sharing, organize the annual conference, collaborate on multicenter publications, and direct two free year-long
high-value care professional development programs (Future Leader Program for trainees and VITAL for early-
career faculty).
This proposal requests support for the 5-7th annual Architecture of High Value Health Care national
conferences. Since its inception, the annual conference has advanced more than 600 value-based quality
improvements initiatives and fostered broad collaboration across academic centers. Presentations from the 1st
four conferences contributed to a blueprint encompassing five key areas health systems must address to
become genuinely high-value medical centers: (1) Diagnostic and therapeutic efficiency and effectiveness, (2)
quality-driven care pathways to reduce unwarranted practice variability, (3) Care transitions and in particular
hospital discharge, (4) Optimizing patient care setting and improving the caliber of ambulatory care, to reduce
avoidable use of the emergency department and hospital, and (5) Preventative medicine to prevent disease
and evidence-based screening from reducing late-stage diagnoses. For the following three conferences, we
will prioritize equitable delivery of high-value care and interdisciplinary teamwork in addition.
Presentations by medical students and trainees are prioritized, as their engagement ensures that value-based
care will become the standard for future generations. Our Future Leaders Program bolsters this mission for
trainees and the Value Innovation Teaching and Leadership Program (VITAL) for junior faculty. The
conference is a critical component of these two programs by fostering a network of high-value care champions
and building a foundation for their future success.

Public health relevance
Project Narrative The Architecture of High Value Health Care annual conference is the premier venue in the United States to disseminate performance improvement initiatives related to high-value practice on a national scale. Now in its 5th year, the meeting serves as a forum for national experts from across the country to vet value-based performance improvement work and a platform to disseminate care redesign that safely improves providers' ability to diagnose and treat patients. Changing long-standing provider practice patterns has proven challenging, necessitating a large-scale demonstration of accountability to inspire adoption of higher value health care and determine which interventions most effectively influence prescribing and ordering behavior.